T SUBSET INTERACTIONS IN SPECIFIC TUMOR IMMUNOTHERAPY

These studies are directed towards definition of the tumor-specific transplantation antigen(s) (TSTA) recognized by Lyt-l+ T effector (Te) and Lyt-2+ T suppressor (Ts) cells responsive to the 51509a (H-2[unreadable]a[unreadable]) methylcholanthrene-induced fibrosarcoma. T cells derived from S1509a-hyperimmune A/J (H-2[unreadable]a[unreadable]) hosts proliferate in vitro in response to soluble tumor-specific protein antigens present in S1509a ascites fluid, predominantly against a 60 to 70 kilodalton molecule with a buoyant density of 1.2-1.32 gm/cc CsCl. Proliferation is specific in that no response is observed with soluble YAC (H-2[unreadable]a[unreadable]) tumor antigens, but appropriate cross-reactivity is exhibited with related SAl (H-2[unreadable]a[unreadable]) soluble antigens. Tumor-specific Ts do not appear to bind the crude antigen preparation, supporting previous observations on the differential specificity of suppressor and effector T cells for S1509a and SAl tumor-associated antigens. A panel of syngeneic monoclonal antibodies (mAbs) reactive with soluble and/or cell-bound 51509a tumor antigens and exhibiting varying degrees of cross-reactivity with other ALJ tumors and with ALJ spleen cells is now being evaluated for recognition of the 51509a TSTA relevant to T-cell immunity. Our second interest is in the administration of anti-class II mAbs as an immunotherapeutic approach to regulating transplantation immunity. Treatment with minor-\or class I-incompatible skin graft prolongs survival 2-\to 3-fold and results in 50% indefinite survival of heterotopic heart allografts. Treatment is associated with delayed development of donor-specific DTH and CTL reactivity concomitant with the appearance of alloantigen-specific T[unreadable]s[unreadable]. Failure to enhance H-2-incompatible graft survival is to the differential recognition of class II versus class I or minor alloantigens by host T[unreadable]s[unreadable]. This therapy may prove beneficial in class II-matched organ transplants, since treatment can be discontinued once suppression has been established, leaving the host response to environmental pathogens intact. (LB)